Center Programs Occ Health

CENTER PROGRAMS, ADMINISTRATION & OPERATIONS OCCUPATIONAL HEALTH & BIOSAFETY SUMMARY Center Programs, Administration & Operations: Occupational Health & Biosafety unit ensures ready access to the necessary information and training that supports workplace safety, productivity, and compliance across all Washington National Primate Research Center (WaNPRC) divisions. This program is designed to ensure that all WaNPRC research, animal care, administrative staff and affiliated personnel comply with a rigorous occupational health & biosafety program.